Multimodal characterization of the mechanisms of selective vulnerability of entorhinal cortical neurons

PROJECT SUMMARY:
Selective neuronal vulnerability is a striking yet largely untapped aspect of Alzheimer’s disease (AD) -during
early prodromal stages, pathological tau protein accumulates almost exclusively in excitatory neurons from
layer II of the entorhinal cortex (ECII). ECII neurons are also the first to degenerate in AD. A large body of
evidence indicates that AD pathological lesions increase the excitability of neurons in the hippocampal
formation, while overall increased network activity accelerates lesion formation. Our recent work suggests that
tau pathology and the regulation of neuronal excitability are particularly tightly linked in ECII neurons, through
cell-autonomous mechanisms. It is therefore crucial to gain a comprehensive view on the mechanisms
modulating electrophysiological properties of ECII neurons, as a pre-requisite to understand the preferential
formation of pathological lesions in these cells. Here, we therefore propose to simultaneously characterize
single ECII neurons at the electrophysiological and transcriptomic levels using Patch-Seq, in order to identify
major intrinsic regulators of ECII excitability, and excitatory/inhibitory (E/I) synaptic balance, as well as their
perturbation in a context akin to early AD. In Aim 1, we will correlate electrophysiological parameters with
individual gene expression and with expression of gene modules that we previously found associated with tau
pathology. By performing Patch-Seq both in wild-type mice and in a mouse model of amyloid accumulation, we
will determine whether amyloid disrupts the ability of certain genes to regulate ECII electrophysiological
properties. Independently, we also have preliminary evidence that an ECII-enriched miRNA downregulated in
AD -miR-129-2- may modulate ECII E/I balance. In Aim 2 we will thus determine the contribution of miR-129-2
to the regulation of electrical properties of ECII neurons. We will inhibit miR-129-2 in vivo and subsequently
profile EC to determine candidate target genes of the microRNA and perform whole-cell patch-clamp
recordings in ECII neurons ex vivo. Taking advantage of the broad range of expression levels of miR-129-2
across ECII neurons, we will then perform Patch-miRNA-qPCR in ECII neurons: we will quantify miR-129-2
levels in electrophysiologically-characterized neurons. This will allow us to determine whether miR-129-2 levels
correlate with certain electrophysiological features of ECII neurons. Taken together the work outlined in this
proposal will identify the major molecular mechanisms by which ECII neurons cell-autonomously adjust their
electrical properties, and how amyloid interferes with this process. This will lay the groundwork for future
studies to determine whether key genes identified here also modulate tau accumulation and vulnerability of
ECII neurons.

Public health relevance
PROJECT NARRATIVE: The reason why specific neurons that are crucial to new memory formation die first and at early stages of Alzheimer’s disease is currently unknown, but excessive electrical activity is one of the earliest signs that they are dysfunctional. In this project, we focus on these very vulnerable neurons, simultaneously recording their electrical activity and creating an inventory of the genes that characterize them, in the brains of normal compared to Alzheimer’s disease model mice. This will allow us to identify the genes that regulate electrical activity and which may represent important novel therapeutic targets to prevent neurodegeneration.